Administrative supplement to purchase a plate reader

Summary
Our current NIH-funded project (GM061146) aims to establish the molecular framework
of RNA NAD+ capping/decapping. In our studies, we routinely perform reporter gene
assays to study how the RNA NAD+ cap affects RNA stability and translation. These
experiments require the use of a plate reader that measures fluorescence and
luminescence. We have been using a plate reader in the Genomics Core facility, but it is
extremely outdated with unstable connections to the computer. Replacement parts
cannot be obtained as the model has become obsolete. We request funds for the
purchase of a SpectraMax iD5 Multi-Mode Microplate Reader. The plate reader is
essential for our NIH-funded research.

Public health relevance
The purchase of a plate reader is essential to the execution of the parent grant that aims to understand the mechanisms and functions of RNA NAD+ capping/decapping. The insights generated by this project will establish new paradigms in gene expression regulation with potential impacts in agriculture and medicine.